UAB KUH KURE

SUMMARY
Innovative and transformational training schemes that motivate the next generation of scientists are needed to
increase the numbers of highly trained PhD investigators and MD physician-researchers in kidney, urology, or
non-malignant hematology (KUH) research. UAB KURE was established in 2018 with recruitment of our first
cohort in 2019 to address this need. The University of Alabama at Birmingham KUH Undergraduate Research
Experience (UAB KURE) R25 program builds confidence and understanding in hands-on research skills and
knowledge of physiological systems in a thriving KUH research environment at UAB. The UAB KURE R25
program has developed professional and career development sessions focused on building confident leaders in
biomedical KUH research. UAB KURE scholars engage in an immersive short-term research training program
with basic to translational hands-on mentored projects, didactic workshops, and clinical experiences with expert
PhD and MD role models in KUH research themes to demystify the complexities of inter-disciplinary KUH
physiology and pathophysiology. The UAB KURE program also exposes undergraduate scholars to
communication and leadership skills through professional development sessions in building confidence to be
leaders in biomedical research. The UAB KURE program utilizes an integrated faculty and near peer team
mentoring approach. It is imperative that faculty mentors engage with the scholars to provide inspiration and
guidance. Moreover, it is well-established that exposure to near peer (graduate students, postdoctoral fellows)
mentorship during influential times in the undergraduate scholar training is key in later career decisions of the
scholars. To optimize near peer mentoring, we initiated a pilot KURE Near Peer Mentoring Academy in 2022.
The Mentoring Academy promoted confidence in near peer mentoring for KURE 2023 as well as in the near
peers' own career development. Furthermore, surveys and focus groups of faculty and near peer mentors
provided key insights to establish best practices for ongoing mentoring of KURE scholar alumni to enhance
opportunities in KUH-focused careers. The mission of the UAB KURE program renewal is to inspire, motivate,
and develop future KUH researchers from diverse backgrounds and experience through an immersive short-
term KUH research and professional development activities. Two specific aims guide the UAB KURE program
renewal. Aim 1 will identify, recruit, and engage a diverse (by race/ethnicity, rural/urban hometowns, scientific
experience, undergraduate institution) cohort of undergraduate students focusing on an immersive summer
research program in the development of inter-disciplinary strategies, critical thinking skills, scientific rigor, and
clinical knowledge in KUH themes at UAB. Aim 2 will develop and nurture an integrated faculty and near peer
mentoring strategy to enrich KURE scholars in communication and leadership skills as well as provide ongoing
mentoring to KURE alumni to enhance future KUH career opportunities.

Public health relevance
NARRATIVE Innovative and transformational training schemes that motivate the next generation of scientists are needed to increase the numbers of highly trained PhD investigators and MD physician-researchers in kidney, urology, or non-malignant hematology (KUH) research. The University of Alabama at Birmingham KUH Undergraduate Research Experience (UAB KURE) program builds confidence and understanding in hands-on research skills and knowledge of physiological systems as well as enhances critical thinking, communication, and leadership skills in a thriving KUH research environment at UAB. The mission of the UAB KURE program is to inspire, motivate, and develop future KUH researchers from diverse backgrounds (racial/ethnic, rural/urban hometowns, scientific experience, undergraduate institutions) through an immersive short-term KUH research and professional development experiences.